Core C: Radiosensitization Core

PROJECT SUMMARY/ABSTRACT (Radiosensitization Core)
The Radiosensitization Core within this SPORE will provide specialized expertise, instrumentation and
technical services to each of the Projects for their research activities related to evaluation of radiation
sensitization of therapeutic agents. These services include irradiation of cultured cells and animal models,
development of treatment plans for conformal irradiation of subcutaneous and orthotopic tumors, evaluation of
therapeutic response using imaging with the goal of optimizing dose and schedule of the combination therapies
in a rational and mechanism driven manner. The Core features three orthovoltage units, a SARRP (Small
Animal Radiation Research Platform) which permits bioluminescence and CT-guided delivery of radiation to
animals as well a laser microirradiation instrument to study DNA repair in single cells. Additionally, the
Radiosensitization Core will be a central conduit for SPORE investigators to access research resources within
the Rogel Cancer Center, including the Pharmacokinetics Shared Resource and the Preclinical Imaging and
Computational Analysis Shared Resource. Dr. Balter, will oversee activities related to image-guided radiation
therapy and conformal treatment planning. Dr. Rehemtulla, will guide studies on mouse models of cancer and
imaging to provide quantitative and mechanistic insights for each of the project-specific therapeutic paradigms.
Dr. Leopold will oversee research related to preclinical optimization of dosing and schedule for test agents in a
manner that informs design of the planned clinical trials in each project. The Radiosensitization Core will also
work seamlessly with the other Cores within the SPORE, the Biostatistics and Computational Biology Core and
the Translational Pathology Core, to ensure that the planning and execution of pre-clinical studies is conducted
with scientific rigor and consistent with the goals of each of the projects. The integration of the
Radiosensitization core with each of the research Projects and the Cores is critical and will provide SPORE
investigators the ability to conduct studies that positively impact the management of patients undergoing
radiation therapy.